Enrichment Program

PROJECT SUMMARY
The overall goal of the Enrichment Program of the Digestive Health Center (DHC) is to advance digestive
disease research by creating a forum where investigators will present new research findings, learn about new
technologies, and pursue new collaborations. The Director of the Program and DHC leaders pursue this goal
with four complementary aims. In the First Aim “to promote knowledge sharing through a weekly seminar and
workshop series,” the Program sponsors a series of highly interactive seminars and presentations by
investigators from the academic health center and extramural scientists who are leaders in digestive disease
research. These seminars also include technology-centered workshops that are given by Core directors and
staff. Presenters receive timely feedback and suggestions on their experimental approaches and emerging
technologies. Seminars and workshops represent a nidus of collaboration and knowledge-sharing among
participants. In the Second Aim “to foster multi-disciplinary research by joint educational programs,” the
Program Director seeks opportunities to partner with focus groups and other specialty Divisions to fertilize
ongoing interests in the field. Examples include the partnership with the “Endoderm Club,” which focuses on
organoid systems to model human disease. In this partnership, extramural distinguished speakers can
participate in the Club’s meetings to present and discuss work-in-progress. We also partner with the Divisions
of Developmental Biology and Immunobiology to expose DHC investigators and trainees to the most
successful scientists in the field. Speakers meet with DHC investigators and trainees. In the Third Aim “to hold
an annual scientific symposium to highlight digestive disease discoveries,” the DHC combines the annual visit
of the External Advisory Board with a day devoted to digestive disease research via a highly subscribed
symposium featuring a distinguished speaker and a scientific forum for the presentation of posters reporting
novel findings by trainees and junior faculty. And in the Fourth Aim, “to increase visibility for digestive disease
research in the Academic Health Center” the Program publishes a quarterly Newsletter that is circulated
throughout the academic health center to share information on upcoming seminars, accomplishments and
awards of DHC investigators, and updates of Core services.